Phenotypic and adaptive consequences of chromosomal rearrangements

Summary: Recent advances in genomic methods have made it possible to characterize the genes and even
mutations contributing to adaptation in a variety of organisms. However, most of our knowledge of genetics
falls short of pinpointing causal variants in sets of point mutations, and we have mounting evidence that
chromosomal rearrangements, that is structural variants (SVs), such as deletions, duplications, inversions
and translocations, play a major role in trait variation and adaptive evolution. The research projects
outlined in this proposal will investigate the contribution of SVs to trait variation and adaptation in three
insect systems: Timema stick insects, Callosobruchus maculatus seed beetles, and Lycaeides butterflies.
The overarching questions to be addressed are: How common are different types of SVs? How do they affect
trait variation? And what processes maintain SVs in natural populations? Answering these questions will
immediately advance our understanding of the material basis of adaptive evolution and has longer-term
implications for understanding trait variation in diverse organisms, including humans.
Previous work in my lab implicated SVs in (i) the evolution of cryptic coloration and host use in
Timema stick insects, (ii) rapid adaptation to a low-quality host plant, lentil, in C. maculatus seed beetles,
and (iii) hybrid fitness in Lycaeides butterflies. Proposed work in each system will combine multiple
chromosome-level phased genome assemblies, population genomic data, and computational modeling to
build on past results and elucidate the general importance and evolutionary history of SVs in these systems.
In Timema, work will focus on the evolutionary history of the diverse SVs associated with color and color
pattern in different populations and species, and on the phenotypic and adaptive relevance of genome-wide
SVs. Proposed work in C. maculatus will shed additional light on the reuse of SVs by determining whether
the same SVs confer adaptation to the same and different hosts in geographically distinct populations,
and whether these same SVs affect fitness in hybrid beetle populations. In Lycaeides, planned projects
will elucidate processes driving contemporary evolution of SVs and connect these SVs to trait variation
and fitness in current and ancient hybrids.
Overall, this research program will provide a comprehensive assessment of the importance of SVs for
trait variation and adaptation across diverse systems that span different time scales (several generations to
millions of years) and contexts (cryptic coloration, host use, contemporary evolution and hybrid fitness).
By identifying the mechanisms responsible for the maintenance of SV polymorphisms within populations
and species, this work has broader implications for understanding the genetic basis of adaptive evolu-
tion. Additionally, insights gained from this research could inform our understanding of the genetics and
evolution of human health, given the relevance of SVs in human genomics and disease-related traits.

Public health relevance
Project Narrative: A more complete understanding of the genetic basis of trait variation and biological adaptation remains a major goal in biology with implications for human health, including enhancing early disease detection, precision medicine, and personalized risk assessment. Mounting evidence suggests that large chromosomal rearrangements, such as deletions, duplications, inversions and translocations of chromosomal segments, have a disproportionate eects on traits and possibly on human diseases. This project will provide foundational knowledge about the possible impacts of chromosomal rearrangements by analyzing their eects and evolution in three insect systems.